Regulation of the Cardiac Sodium Channel by Sumoylation

The cardiac Na+ channel SCN5A (Nav1.5) and the inward depolarizing Na+ current (INa) play a critical role
in regulating the action potential of myocytes in the atrium, ventricle, and specialized conduction system.
Mutations in SCN5A are associated with several arrhythmia phenotypes including long QT syndrome,
Brugada syndrome, and dilated cardiomyopathy. In addition, loss of Na+ channel function is observed during
heart failure, leading to conduction slowing and ventricular arrhythmias based on re-entrant mechanisms.
Small Ubiquitin-like Modifiers (SUMOs), post-translationally modify lysine residues on proteins. Decrease
in SUMOylation of cardiac calcium-handling proteins is associated with human heart failure. The significance
of SUMOylation in regulating cardiac electrical activity is not known. Our preliminary data identifies a
polymorphism in the SUMO1 gene that associates with appropriate defibrillator shocks in patients with heart
failure, suggesting that SUMO1 modifies arrhythmia risk. Given our prior work demonstrating that acetylation
of SCN5A on a lysine residue decreases cardiac sodium current, we now hypothesize that in addition to
acetylation, SCN5A is post-translationally modified by SUMOylation, and SUMO-SCN5A is vital for the cardiac
Na+ current and for normal electrical activity in the heart. This hypothesis is based on very novel preliminary
data that SUMO1 modifies SCN5A and stimulates the Na+ current, whereas de-SUMOylation inhibits INa and
precipitates cardiac arrhythmias in vivo.
This application will explore in-depth the role of SUMOylation and de-SUMOylation on the cardiac Na+
current , characterizing their effect on channels properties, expression, ubiquitination, acetylation, trafficking,
and interaction with its known partner Sirtuin1. The proposal will identify the lysine residues in SCN5A that are
SUMOylated, and explore the importance of SUMOylation of these lysines on the cardiac Na+ current. It will
develop and use state-of-the-art biological reagents, including a novel non-SUMOylatable Nav1.5 knockin
mouse, cardiotropic viral vectors to SUMOylate and de-SUMOylate Nav1.5 in vivo, and transgenic mice
overexpressing SUMO proteins. It will leverage the expertise of basic and mouse electrophysiologists,
molecular biologists, and experts in cardiac SUMOylation. Using these reagents, and with the collective
expertise of the investigative team, it will determine if SCN5A SUMOylation is altered in heart failure, and if
cardiac SUMOylation modifies arrhythmic risk in failing and non-failing hearts.
SUMO modification of SCN5A will identify a new mechanism for regulation of cardiac INa, and one that has
potential clinical relevance in patients with heart failure. In doing so, it will open the door for using SUMO
proteins as therapeutic agents in patients at risk for cardiac arrhythmias.

Public health relevance
PROJECT NARRATIVE This project will determine if modification of a cardiac ion channel that conducts sodium by a small protein (called SUMO) is required for normal electrical activity in normal and failing hearts. This sodium channel in heart muscle is vital for normal propagation of electrical activity in the heart, and malfunctions in heart failure and some genetic diseases that cause sudden cardiac death. Understanding how this channel is regulated by SUMO will shed new light on how its malfunction leads to disturbances in cardiac rhythm.